STUDY EVALUATING SDZ RAD IN DE NOVO RENAL TRANSPLANT RECIPIENTS

Ten patients are enrolled in RADB 157. Enrollment in this study began in spring 1998, and ended in December, 1998. We have one patient who was discontinued due to rejection. The other nine patients are all doing well and will continue with the study.